Anga Center Capacity Building Core

PROJECT SUMMARY
Residents of climate vulnerable communities—defined as those most susceptible to, or unable to cope
with, adverse effects of climate change (CC), including climate variability and extremes—and marginalized
populations, especially, women, youth, and people living with disabilities have a profound stake in the global
community's understanding of CC and health and strategies to adapt to the climate crisis. Research suggests
that bottom-up approaches to CC and health research that actively engage participation of local communities
and leverage and strengthen local capacities ensure reduced vulnerability. This is the key principle of the
Capacity Building Core. The overall goal of the Anga Center's Capacity Building Core is to enhance local and
regional CC and health science and research by investing in infrastructure, early-career researchers, and climate
vulnerable communities and by building the knowledge and technical and scientific skills of and relationships
between future CC and health researchers and communities in multi-directional ways. One of our strategies for
achieving this goal is to support communities most vulnerable to CC and early-career researchers in CC and
health and to cultivate meaningful relationships and knowledge-sharing between the two.
There is incredible potential to enhance CC and health research and CC adaptation particularly in low-
income countries (LICs), through investing in local climate-related infrastructure, facilitating community-based
learning, co-producing knowledge, and increasing the usability of climate science information. Using a multi-
pronged, non-hierarchical, equity-focused approach, the Capacity Building Core will work to achieve these goals
in East Africa. Through the installation of relatively low-cost local weather stations that can be integrated into
existing national and regional weather and climate monitoring networks; investments in capacity-building
opportunities for climate vulnerable communities; and knowledge integration and exchange between scientists,
researchers, and community members, the Capacity Building Core will strive to enhance local and regional CC
and health science and the co-production and utilization of knowledge for and within these communities (Aim
1). Recognizing the critical importance of encouraging and supporting early-career investigators in CC and health
we will focus part of the attention of the Capacity Building Core on supporting a multinational, multidisciplinary
cohort of future leaders of climate change and health (FLCCH) PhD students through fellowships, mentorship,
trainings, seminars, workshops, and hands-on research opportunities (Aim 2). Finally, the Capacity Building
Core will focus on promoting interdisciplinary research and fostering authentic partnerships between CC
scientists, health investigators, and climate vulnerable communities or populations through a pilot research
project program (PRPP). The PRPP will provide interdisciplinary teams of researchers, including at least one
early-stage researcher, funding to carry out a community-engaged pilot research project and mentorship support
to apply for extramural funding using the data collected during the pilot project (Aim 3).